BCCMA: Determinants and early detection of metastasis in melanoma for unmet needs of Veterans with mucosal melanomas affecting the head, neck, and other rare types

Overall Research Strategy: Advancements in melanoma research and treatment over the past twenty years
have not significantly benefitted Veterans and other patients with rarer melanoma types. These include mucosal
melanomas (MM), which affect the head, neck, and anogenital skin; and acral melanomas (AM), occurring on
the palms and the soles, which have striking genetic similarities to mucosal melanomas. The distinct clinical,
molecular, and genetic characteristics of MM and AM represent a barrier to the straightforward application of
current melanoma targeted therapies and immunotherapies and will require a focused approach for early
detection of primary and metastatic disease and effective treatment of advanced disease. Our overarching
hypothesis is that understanding the development and progression of acral and mucosal melanomas from
melanocyte and melanocyte stem cell (McSC) precursors, in the context of genetically and phenotypically
relevant mouse melanoma models with the experimental application of rational treatment options, will advance
our ability to detect and treat these tumors in Veterans before irreversible progression occurs. We propose to
test this hypothesis as a collaborative project capitalizing on the individual strengths of three seasoned VA
investigators who have devoted their careers to melanocyte and melanoma research. This BCCMA project will
address: CMA1 (Hornyak) – the role of McSCs in AM and MM development, testing rational experimental
therapeutic strategies in a relevant mouse melanoma model and validating key targets in Veteran AM and MM
specimens assembled from 5 VAMCs; CMA2 (Chen) – the role of glutamatergic signaling in acral and mucosal
melanoma development and pathogenesis, including the activity of EPAC in melanoma progression and
metastasis in a GRM1 mouse model highly relevant to acral and mucosal melanoma ; and CMA3 (Setaluri) –
the molecular and cellular roles of EPAC and GRM1 signaling in AM and MM, including signaling activity and its
relationship to melanoma cell differentiation state in circulating tumor cells. The collaborative nature of the award
is critical to enable multiple approaches to this problem that would not be possible within the scope of an
individual award. The projects are interdependent and will leverage the collective expertise of the investigators
in melanocyte and melanocyte stem cell (McSC) biology, murine models of melanoma, therapeutic resistance,
analysis of circulating tumor cells, and melanoma clinical therapeutics to advance knowledge across the
spectrum of AM and MM development.
CMA2 (Chen): Advances in preclinical disease models have been crucial to understand human disorders and
to develop efficacious therapeutics. Melanoma patient survival of advanced melanoma has improved from less
than 10% to approaching 50% currently, however, these improvements have not applied to patients with rare
forms of melanoma including AM and MM. Appropriate experimental models have not been studied intensively
to analyze the development of melanomas in locations corresponding to AM and MM. In CMA2 (Chen), the
contribution of glutamatergic signaling to AM and MM will be investigated based on the compelling preliminary
results presented in this application highlights the need to understand better these rare melanoma subtypes and
glutamatergic signaling. Early AM and MM tumors in highly-relevant mouse models will be characterized to
determine the involvement of EPAC signaling and McSC subtypes to the initiation and maintenance of these
tumors. Experimental treatments will be applied to characterize their contributions upon tumors originating in
locations analogous to acral and mucosal areas in humans. Finally, Veteran AM and MM samples will be studied
to correlate AM and MM drivers with prognosis and treatment to develop improved approaches to detect and
manage these rare tumors before irreversible progression.

Public health relevance
The most serious problems facing patients with rare melanoma subtypes today are delay in diagnosis and lack of treatment options. The rare subtypes of melanomas, acral and mucosal melanomas, have created significant obstacles to better comprehend the basis of the diseases. The lack of understanding and knowledge affected rational designs of treatment modalities. This collaborative application will begin a systematic characterization of acral and mucosal melanomas to develop more effective diagnosis and treatment options.